Probing the Metabolism and Cellular Roles of 2',3'-Cyclic Nucleotide Monophosphate

Abstract
Novel intracellular small molecules, 2’,3’-cyclic nucleotide monophosphates (2’,3’-cNMPs), have recently
been discovered within both prokaryotes and eukaryotes. Within plants and mammals, wounding has been
found to cause increased levels of 2’,3’-cNMPs. Preliminary studies in bacteria suggest that 2’,3’-cNMPs
also are produced in response to cellular stress and that 2’,3’-cNMP levels affect bacterial phenotypes, such
as biofilm formation and motility, and expression of numerous genes. The long-term goal of this research is
to understand the roles of 2’,3’-cNMPs in controlling prokaryotic signaling pathways and to utilize this
knowledge to design small molecules to modulate cellular phenotypes. This goal will be addressed by
investigating the cellular components involved in 2’,3’-cNMP metabolism, identifying 2’,3’-cNMP sensors,
and determining the effects of 2’,3’-cNMPs on downstream pathways in a wide range of bacteria. The
proposed work outlines an innovative research plan to probe a novel cellular stress-sensing mechanism and
will provide molecular level details about the nucleic acids and proteins involved in 2’,3’-cNMP metabolism,
as well as the downstream cellular phenotypes. The proposed studies also will expand knowledge of
cellular mRNA decay pathways within bacteria because 2’,3’-cNMPs are products of mRNA degradation.
This work is anticipated to yield the following expected outcomes. First, it will identify the proteins
responsible for 2’,3’-cNMP production and degradation in vivo, as well as 2’,3’-cNMP binding proteins that
may control downstream phenotypes. These studies also will highlight the distribution of 2’,3’-cNMPs within
the bacterial kingdom and extend our understanding of mRNA decay within prokaryotes. Second, the
proposed work will identify the effects of altering 2’,3’-cNMP levels in an array of bacteria, including changes
in gene expression, phenotypes, and key metabolic pathways, including nucleotide/nucleoside metabolism.
Third, elucidating conditions that alter 2’,3’-cNMP levels and phenotypes controlled by 2’,3’-cNMPs will
highlight their role in bacterial responses to cellular stress, particularly with regards to cellular proliferation
and biofilm formation, and illuminate additional effects of stress on mRNA decay. The proposed work will
have an important positive impact by dissecting the cellular roles of 2’,3’-cNMPs within bacteria, which will
highlight novel pathways within prokaryotes and, in the future, potentially can be engineered to control
bacterial proliferation.

Public health relevance
Project Narrative The proposed studies focus on elucidating a novel pathway in bacteria that responds to cellular stress. Investigating members of the pathway and the downstream cellular effects will contribute to an improved understanding of how bacteria sense and respond to their environment. The proposed research is significant because novel bacterial stress response pathways may provide new targets for antibacterial agents.